Refinement and validation of a symptom report-based food allergy prevalence questionnaire for population-based studies

Project Summary/Abstract: While there is general agreement that IgE-mediated food allergy prevalence has
increased in recent decades, the estimation of its population-level burden is complicated by increased
awareness of a variety of food-induced conditions (e.g., intolerances, pollen-food allergy syndrome, celiac
disease). Unlike other survey instruments that evaluate chronic diseases like asthma, symptom-report-
algorithm based survey instruments often utilized for food allergy prevalence estimation remain unvalidated
among the general US pediatric and adult populations. By validating these algorithms via gold-standard clinical
diagnostic methods, the ability to conduct routine disease surveillance, advance treatments, understand clinical
management, and evaluate emerging allergy prevention interventions, will each be greatly enhanced.
First (AIM 1), we will assemble an expert Delphi panel to develop a bank of FA survey questions
that assess key features believed to most accurately, reliably predict true, IgE-mediated food allergy and
capture key differential diagnoses for specific allergies (e.g. lactose intolerance for milk allergy). This bank will
build upon our established, previously administered National Food Allergy Prevalence Questionnaire.
Next (AIM 2), a comprehensive clinical validation study of this survey instrument will be
conducted by sampling participants from the general US population residing within the US Census
Designated Combined Statistical Areas containing Houston, New York City, and Chicago. Surveys will be
completed by 6000 households (obtaining survey responses for roughly 10,000 individuals). 720 individuals
reporting ≥1 current food allergy and 40 with no reported FA will be evaluated for reported “top 9” food allergies
including allergens that meet and do not meet the refined algorithmic “convincing” criteria. A standardized
diagnostic approach adapted from the NIAID-supported Consortium for Food Allergy Research will be used.
Finally (AIM 3) we will analyze the survey and clinical data collected in Aim 2 to provide clinically-
confirmed estimates of peanut, milk, egg, tree nut, shellfish, fin fish, wheat, soy, & sesame allergy prevalence.
We will also finalize our Food Allergy Prevalence Questionnaire, along with a newly developed “short-form” of
the prevalence questionnaire using only the most strongly predictive questions.
By carrying out the proposed research, we will: 1) enhance understanding of widely-cited food allergy
prevalence estimates previously published by our group and currently used to guide policy and public health
decision-making; 2) validate and optimize full and short-form food allergy prevalence questionnaires,
establishing their diagnostic properties in diverse population-based samples; and 3) estimate the current
burden of food allergy and related conditions among the general US pediatric and adult populations in three
major US regions (with ≈40 million inhabitants from 8 states), which will be applied to better understand long-
term trends in US allergic disease burden and form the foundation of future food allergy surveillance efforts.

Public health relevance
Project Narrative Survey-based prevalence studies indicate that food allergy is a growing public health concern in the US and globally, however, food allergy prevalence survey instruments have not yet been systematically validated against gold-standard clinical diagnostic tests, and therefore the true population-level burden of disease is unknown. The proposed multi-site project will build-upon and validate widely used food allergy symptom- report-based prevalence survey instruments with state-of-the-art US population-based epidemiological survey sampling and allergist confirmation of self-reported food allergy cases. The refined instruments will also be used to estimate the prevalence of specific food allergies and other food-related disorders in key regions across the United States and we anticipate will form the foundation of future congressionally mandated routine food allergy surveillance efforts.